ACTIVE MIND: An adaptive clinical trial of cognitive training to improve function and delay dementia

PROJECT SUMMARY
Dementia such as Alzheimer's disease (ADRD) is the most expensive medical condition20 in the US
and affects more than 5 million Americans21. Analyses from the ACTIVE study showed that a specific
type of computerized cognitive training (CTa) reduced risk of ADRD among older adults 29% across
10 years22. [Recent follow-up analyses indicate that ACTIVE participants with signs of mild cognitive
impairment (MCI) at baseline randomized to CTa were 23% less likely to be diagnosed with ADRD
across 20 years23]. While these results are encouraging, MCI was not clinically diagnosed and thus
evidence is inconclusive to recommend CT for ADRD prevention. Many efficacious CT techniques
now exist but have distinct cognitive effects. Given that cognitive deficits are varied among those with
mild cognitive impairment (MCI), who are at higher risk for ADRD, a combination of CT techniques
may be most efficacious. Significant knowledge gaps remain as the best CT exercise(s) for those with
MCI is unclear. We were awarded a clinical trial planning grant to design and establish the feasibility
of the ACTIVE MIND trial (AG062368). We propose phase II of ACTIVE MIND, an adaptive random-
ized trial to identify the most efficacious CT exercises to improve everyday function in MCI. We will
further quantify the effect size of CT to reduce incident ADRD among persons with MCI. In this phase
II trial, our primary objective is to determine which CT arm results in the largest functional improve-
ments and has the best probability to reduce ADRD incidence. Our investigators include international
experts in CT, MCI/ADRD, recruitment and retention, neuropsychological assessment, neuroimaging,
biomarkers, and adaptive trial design. Our approach is to compare different CT arms to a stringent
active control condition with equivalent participant expectations. Measures will include innovative indi-
ces of instrumental activities of daily living (IADL), standard cognitive assessments, as well as neu-
roimaging and novel blood-based biomarkers. Potential moderators of CT will be assessed to identify
who benefits. This study is innovative, in the application of adaptive trial methodology to efficiently
identify the most efficacious CT exercises to reduce ADRD incidence in MCI. We further explore neu-
roimaging and blood-based biomarkers as potential moderators of CT outcomes. Our premise is that
targeted CT improves everyday function (i.e., IADL), which subsequently delays ADRD onset. Our
long term goal is to improve older adults' functional trajectories and thereby curb ADRD prevalence.
The contributions will be significant, advancing our understanding of how CT may be successfully im-
plemented to curb ADRD prevalence. Significance is considerable given that an intervention delaying
the onset of Alzheimer's disease by only one year will result in 9.2 million fewer cases of the disease
by 205024.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because dementia is rapidly increasing in prevalence and is the most expensive medical condition in the US. We will implement an adaptive clinical trial to examine which cognitive training techniques enhance older adults' everyday function and successfully delay dementia onset. Thus, the proposed research is relevant to NIH's mission to enhance health, lengthen life, and reduce illness and disability.